Career Enhancement Core

We propose to renew a Career Enhancement Core that focuses on providing predoctoral and postdoctoral
fellows with high-quality research mentoring that will prepare them for careers in tobacco regulatory science
research. The Core is primarily located at the University of Vermont (UVM), but also has postdoctoral fellows
placed at our two collaborating sites, Brown University and Johns Hopkins University. All three institutions also
have highly regarded T32 training programs in addictions research, which allows for rich cross-fertilization
between tobacco regulatory science and addictions research. Consistent with the overarching focus of the
UVM TCORS, this Core focuses on career enhancement around investigating use of tobacco and nicotine
delivery products among vulnerable populations. The leaders of the Career Enhancement Core (Drs. Higgins
and Heil) have a long history of effective collaborative mentoring in their roles as Director and Associate
Director of the UVM T32 training program in addictions research. Eight additional primary mentoring faculty
provide a wide range of expertise in the areas of vulnerable populations, addictions, behavioral science, and
tobacco regulatory science research. Dr. Villanti bolsters our mentoring team's expertise in tobacco regulatory
science. The Career Enhancement Core provides fellows with (a) hands-on research training in tobacco
regulatory science in which they directly assist faculty with implementing the primary UVM TCORS studies
while simultaneously leading pilot studies, (b) opportunities to participate in an ongoing, rotating seminar series
on behavioral science, behavioral economics and behavioral pharmacology, research ethics, and tobacco
regulatory science, and (c) abundant opportunities to present their research at national scientific meetings and
prepare articles for publication in peer-reviewed journals. During the almost 4 years of the current funding
period, we have mentored 14 predoctoral and postdoctoral fellows (4 predocs and 10 postdocs). Our fellows
published 29 peer-reviewed articles supported by the UVM TCORS during the current funding period, including
15 as 1st author. In the current funding period, we have used pilot projects and developmental studies to
ensure that fellows gain experience with independent research, collaboration, and grant writing in tobacco
regulatory science. Going forward, the Core will leverage that experience and our growing expertise in tobacco
regulatory science to establish the necessary infrastructure to prepare our fellows for successful careers in
tobacco regulatory science, respond effectively to FDA rapid response and other initiatives, and to nurture
partnerships and collaborations within the TCORS network. Overall, we feel that this Core is well positioned to
continue and enhance its mission of preparing the next generation of tobacco regulatory scientists.